FOURTH INTERNATIONAL CONFERENCE ON ANTIVIRAL RESEARCH

This proposal requests funds such that travel grants can be awarded to junior U.S. scientists in order to allow them to attend the Fourth International Conference on Antiviral Research to be held at New Orleans, LA, from April 21-26, 1991. The strength of this meeting stems from discussions on diverse aspects of antiviral drug development and the strong support and participation of leading investigators in this field. These investigators include individuals whose interests range from molecular biology and genetics to drug design and synthesis, in vitro evaluation of antiviral compounds, animal models for evaluation of antiviral drugs, modulation of host immune response, pharmacodynamics, pharmacokinetics, and controlled clinical investigations. The U.S. organizer for the 1991 conference is Dr. Richard Whitley, immediate past president for the International Society for Antiviral Research. His European counterpart is Dr. Erik DeClercq, President of the Society.